CHRONIC ORAL 5-FU IN COMBINATION WITH 776C85

The purpose of this proposal is to evaluate the affect of an AW inhibitor of dihydropyrimidine dehydrogenase (DPD) 776C85 used concomitantly with low oral doses of 5-fluorouracil (5-FU). The study will examine the affect of a 28 day dose of the combined drugs on toxicity in a phase I setting in patients with colorectal cancer.